Animal & Tissue Imaging Shared Resource

ANIMAL & TISSUE IMAGING SHARED RESOURCE – PROJECT SUMMARY/ABSTRACT
This Shared Resource provides histology services for the characterization of murine and human tumor tissue
and the evaluation of animal pathology. The samples submitted for analysis are analyzed with the latest
technology and to the highest quality standards. Moreover, Cancer Center members have access to
instrumentation for non-invasive ultrasound, bioluminescence, and fluorescence imaging to advance the
molecular and physiological understanding of cancer biology. Furthermore, the exceptional expertise of the
Shared Resource staff allows collaborative development of innovative approaches to highly specific and
sensitive in vivo imaging using PET/CT and SPECT/CT instruments. These novel methods have particular
application in assessing tumor response to experimental treatment, and to help develop and characterize novel
diagnostic or therapeutic approaches. Overall, the goal of this Shared Resource is to provide support that leads
to a deeper mechanistic understanding of cancer biology, and also to greatly advance the evaluation and
characterization of cancer animal models at the CSHL Cancer Center. This Shared Resource is led by Faculty
Head Lloyd Trotman, Ph.D., Director Scott Lyons, Ph.D, and Manager Qing Gao, Ph.D. In the last five-year
period, this Shared Resource was used by 21 Cancer Center members (55% of members), and resulted in 40
publications or preprints.

Public health relevance
ANIMAL & TISSUE IMAGING SHARED RESOURCE- PROJECT NARRATIVE Not required per PAR-20-043